Tuberculosis: Heterogeneity from Experimental Models to Human Disease

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Tuberculosis: Heterogeneity from
Experimental Models to Human Disease, organized by Drs. JoAnne L. Flynn, Bryan D. Bryson and Henry C.
Mwandumba. The meeting will take place February 16–19, 2025 at the Fairmont Copley Plaza in Boston, MA.
Tuberculosis (TB) is the world’s leading cause of infectious disease death, but despite decades of research,
there remains an incomplete understanding of the immune responses necessary for protection against the
disease. The heterogeneity that exists across many aspects of the disease—from mycobacterial physiology to
cellular responses to Mtb infection, to human responses to infection and vaccination—remains an incompletely
characterized aspect of TB. The goal of this meeting is to bring together scientists from across the globe to
dissect pathogen and host heterogeneity across molecular and clinical aspects of the disease. The program will
also analyze heterogeneity in tissue-level response to infection, as well as human and non-human primate
responses to vaccination. A central theme of the meeting will be highlighting molecular, clinical, and technological
advances that enable better characterization of the variable elements that have the strongest impact on disease
outcomes. By bringing together diverse scientists from across the spectrum of TB research, this meeting will
foster new collaborations to integrate human observations with experimental models, immunologic insights and
molecular profiling, to generate new therapeutic paradigms that are so desperately needed against this disease.

Public health relevance
PROJECT NARRATIVE Understanding the heterogeneous nature of tuberculosis (TB) will be critical to making progress in addressing this complex and deadly disease. This Keystone Symposia conference, Tuberculosis: Heterogeneity from Experimental Models to Human Disease, will focus on defining the knowledge gaps in pathogen and host heterogeneity, which complicates treatment strategies, as a necessary step in optimizing therapeutic interventions and improve patient outcomes. This meeting will bring together an international, multi-disciplinary group of scientists to share new insights into infection and disease and will highlight cutting-edge tools and technologies needed for the design and implementation of new vaccines and treatments for TB.